Defining Mechanical Landscapes at Cell-Cell Junctions

PROJECT SUMMARY/ABSTRACT
The long-term goal of my research group is to develop “next-generation” nucleic acid-based platform for
understanding how living organisms function and for disease diagnostics. In particular, we are creating a series
of DNA probes for measuring cell membrane biophysical interactions, especially the biomechanical features at
cell-cell junctions, as well as developing fluorogenic RNA aptamer-based sensors for targeted imaging inside
living organisms. Our immediate goal for the next five years is to make precise intercellular force measurement
and regulation readily available for implementation in life science laboratories. We will demonstrate how these
novel DNA-based tools can be broadly used to understand the basic mechanical principles of development,
physiology, and disease. These DNA mechanical probes and actuators will also serve as the critical foundation
for developing novel strategies in tissue engineering, regenerative medicine, and cell therapy.
Mechanical forces play fundamental roles in many intrinsic and collective cellular processes, such as
tissue regeneration, morphogenesis, and tumor metastasis. While extensive studies have focused on the forces
between cells and extracellular matrices, mechanical interactions among individual cells appear to be important
yet poorly characterized. These intercellular forces are known to be critical during wound healing, cancer cell
invasion, and other developmental and homeostatic processes. However, the molecular principles that govern
these finely balanced mechanotransduction events are still poorly understood. To depict the mechanisms of
these collective cellular processes, it is essential to measure and fine-tune intercellular forces at the molecular
level, and then correlate the patterns of mechanical landscapes with the specific molecular machineries that
regulate cellular signaling.
In the past project period, we have developed precise and easy-to-use DNA-based fluorescent probes to
visualize and quantify forces at cell-cell junctions. These synthetic DNA probes can spontaneously anchor onto
the external surfaces of live cell membranes and allow sensitive imaging of a broad range of intercellular
molecular forces simply after a brief incubation. During the next 5-year project period, we plan to further develop
highly robust, versatile, and high-throughput DNA-based mechanoprobes and novel mechanical actuators.
These tools will be further used to provide unique insights for elucidating the mechanical mechanisms of several
key collective mechanosensitive cellular events in neural development, cancer metastasis, and immunology.
High-throughput screening platforms will also be validated and applied for the identification of novel modulators
of intercellular forces and potential drug candidates. In contrast to many current mechanobiology studies that
are based on techniques typically performed in only a few specialized laboratories, the DNA probes, actuators,
and screening platforms developed in this project can be potentially widely adopted for measuring and regulating
molecular forces at cell-cell junctions.

Public health relevance
PROJECT NARRATIVE Intercellular forces are critical regulators in multiple physiological and pathological processes. However, these mechanical events are still poorly characterized and lack of precise control. This project aims to further develop reliable and versatile DNA-based mechanoprobes, actuators, and screening platforms, which can be broadly used in understanding and modulating various mechanosensitive intercellular signaling events.